Deafness, vocabulary knowledge, and the emergence of reading efficiency: Evidence from eye-tracking

Project Summary/Abstract
Despite historical reports of lower reading outcomes of deaf and hard-of-hearing (DHH) high school students,
evidence from eye-tracking suggests that skilled DHH adults who learned a signed language before learning to
read are uniquely efficient: They read faster and rereading less than matched hearing readers without a negative
impact on comprehension. What factors lead this subset of DHH children to become highly skilled adult readers?
For hearing mono- and bilingual readers, vocabulary knowledge of the target language strongly correlates with
reading ability. However, while studies have pointed to the emergence of reading efficiency in young DHH
readers, the role of first- (L1) and second-language (L2) vocabulary knowledge has yet to be established
empirically. We use eye-tracking and behavioral language testing to assess the degree to which L1 American
Sign Language (ASL) vocabulary knowledge transfers to L2 English reading comprehension and supports eye-
movement control during reading. L1 ASL vocabulary knowledge may be particularly important for this group of
developing bilinguals for several reasons. First, they do not have typical access to the speech sounds of the
language they are learning to read. Thus, their path to successful literacy may lie in the connection between
visual form in text and word meaning in ASL. Second, they only read in their L2 as ASL has no written form. As
such, while hearing L2 readers are typically less efficient than L1 readers, the exclusive experience processing
text in English, compounded by visual linguistic processing expertise from extracting language information from
visual forms in their L1, may result in highly efficient reading behaviors for DHH signers. To achieve our goal,
we will predict DHH readers’ comprehension on a standardized measure of reading by L1 and L2 vocabulary
skill as well as nonverbal IQ, working memory, print spelling recognition, and fingerspelling recognition (Aim 1).
We will also use eye-tracking to assess the role of L1 ASL vocabulary knowledge while controlling for L2 English
vocabulary knowledge as well as (finger)spelling ability, nonverbal IQ, and working memory on measures of eye-
movement control during reading (L2). We further assess the emergence of adultlike reading efficiency,
particularly regarding the information in text to which they attend (Aim 3). This project will provide insight into the
successful path to literacy for DHH students, as well as other diverse groups of bilinguals and readers for whom
the exploitation of letter-sound correspondences is not beneficial. Results from this project will inform a later R01
proposal which will track the development of reading skill longitudinally and will include a more diverse group of
DHH readers as well as hearing mono- and bilingual controls. This project assesses reading in DHH child signers
from a strengths-based perspective, shifting focus from what these readers cannot do (e.g., hear speech sounds)
to what they can do: Leverage the knowledge of their L1 to acquire an L2 via print. These results may help guide
early linguistic and educational practices for DHH students to optimize literacy achievement.

Public health relevance
Project Narrative This proposal explores how vocabulary knowledge in both American Sign Language (ASL) and English contributes to reading comprehension and efficient reading behaviors in deaf and hard-of-hearing (DHH) children who are first-language users of ASL and second-language readers of written English. The study aims to identify how knowledge of word meanings in both of deaf readers’ languages influence reading strategies and predict the emergence of skilled, efficient eye- movement-while-reading behaviors for these children. Findings will advance our understanding of reading development in DHH children, second language readers of English, and readers for whom sound-letter correspondence does not provide a successful path to literacy and guide curriculum improvements to support their unique learning needs, aligning with public health priorities to enhance literacy in diverse populations.